Berkeley Population Center

SUMMARY/ABSTRACT – OVERALL
The Berkeley Population Center (BPC), now in its 13th year of operations, requests a five-year renewal
(previously an R24) to continue its unique contributions in population research. BPC is a hub connecting
population researchers in different disciplines from across this large campus. Taking advantage of both the
faculty expertise as well as institutional initiatives, the five Primary Research Areas to be supported in the
renewal period include the existing and well-established thematic areas of Formal Demography, Population
Health, and Reproductive Health and HIV. New to BPC is a focus on Data Science and Demography, and
Family Policy. Collectively these methodological and substantive areas contribute basic knowledge to the
determinants of health status and outcomes, and their interdependence with the core demographic processes
of fertility, migration and mortality. BPC is a resource center for the development of new research ideas and
initiatives, doing so with its (a) support for weekly `brown bag' luncheon seminars and frequent mini-
conferences that allow for exposure to a multiplicity to innovative ideas within a congenial networking
environment; (b) dissemination of information about opportunities in population research such as external
funding, calls for papers, workshops and training; and (c) substantial support for grant development. Through
the pilot grant program, researchers have the ability to try out and develop research ideas, and to provide
graduate students participatory opportunities. Our affiliates are from Demography, Public Health, Economics,
Sociology, Public Policy, Social Welfare and other disciplines. In particular, early stage investigators are
welcomed to BPC and given mentored support and financial assistance to advance their intellectual
development and research activity. The affiliates are faculty yet the beneficiaries of the Center include
postdoctoral fellows, population researchers, and students – both graduate and undergraduate – such that the
BPC contributes directly and indirectly to the training of a new and diverse cohorts of researchers. BPC also
benefits from significant institutional support from the College of Letters and Science and the Office of the Vice-
Chancellor of Research ($59,000 annually) matching its commitment to BPC despite a budget crisis, as well as
support from the computing and data center (D-Lab), the Department of Demography, the School of Public
Health, and the new Berkeley Institute for Data Science. Substantial administrative support is provided by the
university. In the past 5 years we have proven success in our productivity as evidenced by our growing grant
portfolio (PDB-funded grants increased from $0.6 million in FY2012 to $2.36 million in FY2017) and the caliber
of our 50 faculty affiliates. BPC is poised to continue its contribution to innovative and interdisciplinary
population research that will transform how we address population challenges in the 21st century.

Public health relevance
PROJECT NARRATIVE – OVERALL The Berkeley Population Center's mission is to create and disseminate valuable research findings about population processes that related to the health and well-being of the residents of this country and beyond. This goal is accomplished through innovative methods, population- based data and tested analytic tools, and a wealth of collaborative and interdisciplinary researchers who focus on population health, health disparities and inequality.